Maximizing Investigators' Research Award (R35)

PROJECT SUMMARY
The “Tools for Transmission of Agents and Conditions (TRAC)” program will synergize statistical and
mathematical modeling work in three areas of application: 1) Tuberculosis (TB) incidence and transmission; 2)
monitoring substance use disorder (SUD) patterns; and 3) SARS CoV-2 transmission modeling. These three
conditions are major public health problems, with TB being the leading cause of infectious disease death globally,
SUD causing more deaths in the United States than HIV/AIDS in its peak, and SARS CoV-2 causing a pandemic
with societal disruption and mortality exceeding anything we have experienced in the last century. We need
improved analytical tools that leverage existing data to monitor these diseases, infer transmission hot spots,
determine the efficacy of interventions, and understand the burden of these conditions.
This program will bring together an expert group of quantitative researchers with skills that are readily applied to
these problems. We also leverage our strong collaborations with clinician researchers and public health officials
to ensure that the methods we develop are addressing important questions and consistent with our current
understanding of these diseases. By creating a program to facilitate communication between these experts, we
will enable greater innovation in modeling key aspects of these diseases and create exciting methodological
synergies across diseases. Our team is well positioned to incorporate data from emerging technologies, including
high throughput sequencing data to determine TB risk signatures and inform transmission links for TB and SARS
CoV-2. Our expertise in machine learning, a broad range of statistical methodologies, and mathematical
modeling will enable us to leverage the rich information in large databases that are emerging to better understand
SUD patterns and identify risk signatures. We will also build infrastructure with our partners to make the analytical
tools that we develop more accessible to public health practitioners and other researchers.
The impact of this work is to develop a suite of analytical tools that leverage rapidly emerging rich data sets to
improve our understanding of disease transmission patterns, monitor changing dynamics of these conditions,
and understand intervention strategies that are most effective. This work will inform public health practice for
these diseases and create reproducible tools that can be used in an ongoing way.

Public health relevance
PROJECT NARRATIVE This project will generate analytical tools to address three major public health challenges: 1) Tuberculosis, 2) Substance use disorders, and 3) SARS CoV-2. These tools will improve our understanding of the transmission patterns of these diseases, advance our ability to monitor them, and inform intervention strategies. We will build infrastructure to make these methods available to public health practitioners and other researchers.